Prox1 and oscillatory shear stress in aortic valve development and homeostasis

Project Summary
Congenital aortic valve malformations, including bicuspid aortic valve, occur in approximately 2% of live births,
and acquired heart valve diseases, such as calcific aortic valve disease, occur in about 2.5% of the U.S.
population. It is theorized that mechanical forces influence both congenital and adult valve disease. Recently
phenotypic and transcriptionally diverse aortic valve (AoV) cell populations were identified using single-cell RNA
sequencing of maturing murine aortic and mitral valves. For the first time, three distinct valve endothelial cell
(VEC) populations were identified in specific locations on the AoV. Each location experiences a unique
combination of mechanical forces which could be important in diversifying VEC subpopulations. Importantly, one
of these populations is present on the fibrosa side of the AoV where the VECs experience OSS. This population
preferentially expresses the transcription factor Prox1, a master regulator of developmental processes, including
cell fate and gene expression, in multiple organ systems. In the lymphatic system, Prox1 acts as a key regulator
of lymphatic valve (LymphV) development and homeostasis in response to OSS. As Prox1 is present on the
fibrosa side of murine embryonic day (E)13.5 semilunar valves and Prox1 remains present into adulthood, it is
predicted that a similar mechanism is active during AoV development and homeostasis. The central hypothesis
of this proposal is that Prox1 mediates aortic valve morphogenesis and homeostasis in response to changes in
shear stress. Aim 1 will determine if fibrosa side-specific Prox1 promotes morphogenesis and homeostasis in
the aortic valve by analyzing the expression pattern of Prox1 in the AoV of embryonic and adult mice throughout
valve development and homeostasis. In parallel, the expression pattern of Gata2 and Cx37, Prox1’s inducer and
downstream target in LymphV endothelial cells respectively, will also be analyzed (1A). Additionally, embryonic
and adult endothelial-specific Prox1 loss-of-function mice will be utilized to study the effect Prox1 deletion has
on Gata2 and Cx37 expression, as well as on valve morphology (1B). In Aim 2, the effects of altered shear
stress on a Prox1 regulatory network and its relationship to valve homeostasis and disease will be analyzed.
First, the expression pattern of Prox1, its lymphatic inducer (Gata2) and downstream target (Cx37) will be
examined in porcine AoVs and in healthy and diseased human AoVs (2A). Next, the impact of physiologically
relevant aberrant shear stress patterns on Prox1 in porcine AoV leaflets cultured ex vivo will be studied using a
single cone-and-plate bioreactor (2B). Our long-term goal is to identify mechanosensitive mechanisms of AoV
development, homeostasis and disease with potential therapeutic applications. This training plan combines
studies of valve biology and bioengineering with translational implications. My career goal is to become a leader
in understanding how the mechanical environment influences cardiovascular development, homeostasis and
disease.

Public health relevance
Project Narrative Congenital aortic valve malformations, including bicuspid aortic valve (BAV), and adult onset valve diseases, such as calcific aortic valve disease (CAVD), are thought to be influenced by aberrant blood flow patterns and the reemergence of developmental pathways. While valve disease is common, the only treatment option currently available is valve replacement surgery which is costly and often a temporary solution. This proposal seeks to identify a relationship between aberrant blood flow patterns, aortic valve development, and valve disease with the ultimate goal of developing new therapies.